2025 Salivary Glands and Exocrine Biology Gordon Research Conference and Seminar

PROJECT SUMMARY
This proposal seeks support for the 14th Gordon Research Conference (GRC) on “Salivary Glands and
Exocrine Biology”, subtitled Preclinical Modeling, Engineering & Therapeutics for Glandular Diseases.
The GRC takes place at the Sheraton Hotel venue in Ventura, CA on January 26-31, 2025, and a prelude is
the 4th pre-conference Gordon Research Seminar (GRS) for trainees on January 25-26.
The overall objective of the 2025 GRC/GRS is to catalyze innovative thinking in areas where basic, pre-clinical,
and translational research lead to improvements in human health, promote high-quality collaboration among
researchers using new approaches to advance the field, to honor pioneering work in the field, and to transmit
knowledge and inspiration to a younger generation in continuing a legacy of innovative science. An important
goal is to provide trainees sufficient interactions with experts in the field and encourage participation of those
who are traditionally under-represented in science, including women, members of minority groups, and
persons with disabilities.
With the 2025 GRC/GRS, a precedent is taken to integrate a vast variety of new innovations on 3 different
levels. First, the plenary sessions covering the 2025 GRC builds on a myriad of current status-quo research
topics and integrates new technical novelties across a variety of exocrine tissues (e.g., salivary, lacrimal, and
submucosal glands, lung, and pancreas). Both basic and pre-clinical research, as well as clinical adaptation of
therapeutics are covered in the areas of cancer, radiation-induced xerostomia, Sjögren disease, aging, and
diagnostics. A fitting ratio based on seniority, gender, and geographical position from around the globe is
considered for invited speakers, and all attendees can participate in poster sessions. Mini-talks are included to
highlight late breaking abstracts. The second focus lies with training the next generation of diverse scientists by
enhancing trainee networking, discussions on careers within and outside academia (GRS), and a ‘senior
investigator-trainee’ lunch discussion (GRC). Thirdly, professional growth for GRC/GRS attendees is made
available through a plethora of previously incorporated GRC activities mixed with new opportunities, including
a Power Hour, podcast series, think-tanks on relevant topics in the field, and a corporate-guided state-of-the-
art technique session.
Overall, this conference seeks to bring together a diverse group of senior experts and trainees to present the
current state of scientific findings, formulate new ideas and discussions, form high-quality collaborations, and
drive innovation in the field to improve human health.

Public health relevance
PROJECT NARRATIVE Exocrine biology includes pancreas, lung, salivary, lacrimal, and submucosal glands, as well as other mucosal and external surfaces. Current research on exocrine organs is focused on prevention and repair of insults to these tissues in the context of cancer, radiation, aging, and autoimmune disease that lead to loss of organ function. The objective of the 2025 GRC/GRS on “Salivary Glands and Exocrine Biology” is to inspire diverse scientists, to catalyze high-quality scientific exchanges and state-of-the-art technologies, and to promote collaborations in disciplines related to exocrine biology and disease that majorly impact human health.